Role of proteasome activity in adaptive immunity

Project Summary
Mortality from infectious diseases remains a leading cause of death worldwide,
making the development of new vaccines an important priority of biomedical research.
Immunologic memory is a cardinal feature of adaptive immunity and an important goal of
vaccination strategies. Traditional vaccination strategies are very effective at generating
neutralizing antibodies against bacteria and viruses. However, a vaccine capable of
generating robust T lymphocyte memory is still beyond our research, due, in part, to an
incomplete understanding of how lymphocyte fates are specified. In this grant
application, we propose to study the role of proteasome degradation activity in
controlling this process.

Public health relevance
Project Narrative T lymphocytes are cells of the immune system that provide protection against infections. Vaccines generate different types of protective T lymphocytes. Our goal is to test new strategies that may improve vaccine efficacy.